I. Institutional Career Development Core

The mission of the Institutional Career Development Core (KL2) is to train, mentor, and develop the next generation of skilled, independent researchers to conduct high-quality clinical and translational research and prepare them to meet the challenges of the current and future complex investigative environment. The KL2 Program has established a track record of providing training for new and emerging technologies (e.g. Nanotechnology, Bioengineering, and Biomedical 3D Printing) in addition to core competency training. Our KL2 graduates have made groundbreaking contributions to the field, and numerous KL2 professional development initiatives have been introduced to inspire innovative research moving forward, include Advanced Certificate in Clinical/Translational (C/T) Investigation and the; a Master’s Program in Clinical and Translational Investigation The Entrepreneurs in Residence Program, where successful entrepreneurs serve as mentors to Scholars and students; the CRESS program, consisting of seminars given by Alumni who discuss their path to success in research and academia, industry, or government; and the Career and Professional Development Workshop. Additionally, the CTSC Health Hackathon was created to cultivate our Scholars’ creativity with a focus on cross-disciplinary teamwork that will stimulate the development of transformative advances in medicine. Great care is taken to ensure that Scholars are matched with highly skilled and trained mentors who are dedicated to nurturing the next generation of healthcare leaders. Mentored Grant writing programs are also provided to help KL2 Scholars and other researchers obtain funded research proposals. Moreover, Scholars can get research support from National Research Support Services and CTSC Research Support Services as needed. With newly expanded initiatives involving creativity, entrepreneurship, team science, precision medicine, informatics, a highly skilled cadre of Scholars will be equipped to tackle the complex biomedical challenges with innovative and impactful solutions to accelerate the clinical and translational continuum. In the proposed funding period, the Program will leverage the strengths of Weill Cornell CTSC, its partners, its resources, and other active collaborators to enable basic and clinical Investigators to achieve successful independence and make significant contributions to the field of Clinical and Translational research. The successful programs will be made available throughout the CTSC network. The planned duration of appointments, is two years, with an optional year if necessary, (e.g. surgeons at 50% time) to three years and their projected number of scholars is (8) and includes early to mid-career, postdoctoral, faculty.